Mapping the Time Course of mTORC1-Driven Tumorigenesis in the Developing Brain

SUMMARY
The mammalian target of rapamycin complex 1 (mTORC1) signaling pathway regulates cell size and growth
and is frequently mutated in disease, including in a class of neurodevelopmental disorders known as
“mTORopathies.” One such disorder, Tuberous Sclerosis Complex (TSC), affects nearly 1 in every 6,000
newborns and is characterized by the growth of benign tumors throughout the body. TSC is caused by an
inactivating mutation in the genes that encode the negative regulators of mTORC1, leading to protein loss of
function, hyperactivation of mTORC1, and increased cell proliferation through phosphorylation of ribosomal
protein S6 (p-S6) and eukaryotic translation initiation factor 4E-binding protein 1 (p-4EBP1). Twenty percent of
TSC patients develop a large tumor that preferentially presents near the ventral region of the ventricular-
subventricular zone (V-SVZ), the largest neural stem cell niche in the adult brain. Recent studies of neural
stem cells in the V-SVZ revealed variable transcriptional and functional capabilities corresponding to a cell’s
position along the dorsoventral axis of the V-SVZ, including differential activation of mTORC1 and susceptibility
to TSC tumor formation. Further, different populations of neural stem cells in the niche are mitotically active at
different times throughout pre- and postnatal neural development. Postnatally, mTORC1 has been shown to be
important in regulating neural stem cell quiescence, but mTORC1 signaling in the prenatal V-SVZ and its effect
on quiescence in embryonic neural stem cells has not been investigated. The goal of this project is to
determine the developmental stage when differential mTORC1 activity emerges along the dorsoventral axis of
the V-SVZ and the extent to which dysregulated mTORC1 signaling alters cell fate. The central hypothesis of
this project is that levels of mTORC1-dependent p-4EBP1, but not p-S6, determine both a prenatal neural stem
cell's mitotic activity and susceptibility to TSC tumor development. To test this hypothesis, an inducible mouse
model and pharmacologic agents will be used to manipulate mTORC1 signaling during embryogenesis. To
map the emergence of differences in mTORC1 activity in healthy and disease states, per-cell levels of
mTORC1-dependent phosphorylation events will be quantified via imaging and flow cytometry analyses of
embryonic neural stem cells. To compare results across species and platforms, mTORC1-dependent signaling
will be quantified in cerebral organoid models grown from induced pluripotent stem cells derived from TSC
patients. Through this project, I will build upon my prior training to evaluate cell signaling and differentiation in
human and mouse models of disease. Results of this work will determine the role of mTORC1 in regulating
prenatal neural stem cell fate in health and disease. Clinically, this work will provide a greater understanding of
the dysregulated signaling mechanisms that lead to perinatal development of tumors in the V-SVZ and identify
potential suitable time points for therapeutic interventions for patients with TSC and other mTORopathies.

Public health relevance
PROJECT NARRATIVE Patients with Tuberous Sclerosis are born with a loss of function mutation in the mammalian target of rapamycin (mTOR) signaling pathway that regulates cell size and growth, causing the formation of large tumors in nearly every organ system. The proposed research will characterize patterns of mTOR signaling in prenatal neural stem cells using both mouse and human models to determine the time window during embryonic development in which dysregulated mTOR signaling is sufficient to alter cell fate and contribute to tumor growth. Results from this project will construct a timeline of mTOR signaling in healthy neural stem cells and alterations that occur in disease states, providing insight into the window of opportunity for prevention or mitigation of brain tumors in patients with Tuberous Sclerosis.